Exposure to Suicide Among Post 9/11 Veterans: Prevalence, Correlates and Treatment Needs

Background: The toll of suicide goes way beyond the death of an individual. Those exposed (defined as knowing
the person) to a suicide death are at elevated risk for mental illness, physical disorders, impaired social
functioning, and fatal and nonfatal suicide behavior. Conclusions from the handful of studies that have examined
this topic among Veterans are limited by distinct samples, limited sample sizes and other methodological issues.
Additionally, the numbers of women and minority race/ethnicity service members and Veterans in these studies
were too small to examine what are likely critical differences by sex and race.
Significance: This study will provide foundational information on an understudied risk factor for suicide in a
cohort of Veterans at increased suicide risk – post 9/11 Veterans within six years following military separation. It
will provide information to inform suicide postvention strategies that target the population of suicide bereaved
post-9/11 Veterans as well as those targeting women and American Indian/Alaskan Native (AI/AN) Veterans.
Innovation and Impact: (1) Use of VA data to provide the most reliable prevalence estimates for suicide
exposure among Veterans to date; (2) Oversampling of vulnerable but understudied populations -- Women and
AI/AN Veterans; (3) inclusion of two comparison groups to elucidate the common and unique contribution of
suicide exposure to health outcomes and patterns of VA service utilization; and (4) Assessment of the formal
and informal supports Veterans receive for mental health problems associated with suicide using both survey
and VA healthcare utilization data.
Specific Aims: (1) Evaluate differences in the prevalence of posttraumatic stress disorder (PTSD), prolonged
grief disorder (PGD), and in suicidal ideation, attempts and planning among Veterans exposed to suicide
compared with those exposed to other causes of sudden death and with unexposed Veterans. We will also
evaluate differences by sex and race. (2) Identify modifiable moderating factors for the association between
suicide exposure and negative outcomes and modifiable moderating factors for the association between suicide
or sudden death exposure and negative outcomes relative to those with neither exposure. (3) Describe treatment
experiences, interests, reported suicide attempts, and patterns of VA service utilization among those exposed to
a suicide death compared to Veterans exposed to other sudden deaths and to unexposed Veterans. (4)
Contextualize quantitative findings through interviews with a purposive sample of Veterans exposed to suicide.
The interviews will focus on modifiable factors at each level of the socio-ecological model of suicide prevention
to better understand targets for intervention.
Methodology: This explanatory sequential mixed methods study examines outcomes associated with suicide
exposure in a nationally representative sample of post-9/11 Veterans enrolled in VA healthcare. We will collect
data in three waves. Wave 1 will implement a national population probability sample using a brief survey to
assess exposure history (suicide, other sudden death, neither) and exposure characteristics (e.g., time since
exposure) among 11,400 Veteran respondents. Wave 2 will survey Wave 1 respondents, stratified by exposure
history (suicide, sudden death, neither), to assess outcomes and variables of interest among 4,500 Veterans
(1,500 respondents per exposure group). Wave 3 involves interviews with a purposive subsample of 32 Waves
2 survey responders who have been exposed to suicide but differ in outcomes. Quantitative analysis is the
priority of the study; the qualitative component will contextualize the quantitative findings.
Next Steps/ Implementation: This work will direct VA and the field towards an understanding of the most critical
outcomes among veterans exposed to suicide, the mechanisms that may lead to deleterious outcomes, and lay
a foundation for understanding the effective treatments and supports needed for Veterans who experience a
suicide loss, including women and AI/AN Veterans.

Public health relevance
Suicide is a national public health problem that disproportionately affects Veterans. However, the toll associated with suicide goes way beyond the death of an individual. This study addresses the problems that it is unknown how many Veterans need intervention following exposure to suicide, what types of problems should be addressed and what intervention approaches might be most beneficial. The primary objective of this study is to describe the health and functional outcomes of suicide exposure among a cohort of Veterans at particularly high risk for suicide and of priority for VA suicide prevention strategies – post-9/11 Veterans transitioning to civilian life. Our second objective is to elucidate the reasons some Veterans develop persistent problems following suicide exposure while others do not. This study starts with quantitative (which is the priority of the study) followed by qualitative data collection and analysis to explain and expand the quantitative findings. Findings can inform strategies to support Veterans affected by a suicide loss.